Development of a Machine Learning Prediction Model for the Detection of Meniere's Disease from Cerumen Chemical Profiles

ABSTRACT/PROJECT SUMMARY for Supplement Request on Alzheimer’s Disease and Related Dementias
[NOT-AG-22-025] (Parent Project: R21DC02056501)
Alzheimer’s disease and its related dementias (ADRD) afflict ~50 million people worldwide. Although testing
methodologies to diagnose and differentiate different forms of dementia have been investigated for decades, the only
definitive means to confirm a diagnosis of ADRD is at autopsy. Diagnosis is slow and is often based on exclusionary criteria
along with the results of multiple forms of costly testing. However, if more readily accessible chemical markers of ADRD
can be identified, rapid and accurate diagnoses could be accomplished based on assessment of the presence (or absence)
of relevant compounds. Such an achievement would revolutionize ADRD diagnosis in terms of methods and cost, and could
even reveal other dimensions of disease pathogenesis and progression that might shed light on disease etiology, and lead
to alternative, more effective treatments.
It is hypothesized here that based on research findings that reveal that ADRD manifests in part in terms of changes in lipid
profiles, the chemical profile of the lipid-rich cerumen matrix may serve as a reporter of the presence of ADRD, and that
cerumen profiles may differ as a function of dementia type. Knowledge of these differential profiles can be leveraged to
accurately and rapidly reveal the presence of ADRD via the application of machine learning algorithms to the chemical
data. This hypothesis will be investigated through pursuit of the following specific aims:
Specific Aim I: Determination of the mass spectrum-derived chemical signatures of cerumen from healthy donors,
Alzheimer’s disease (AD) patients, and patients diagnosed with other dementias.
Specific Aim II: Development of machine learning prediction models that enable accurate determination of the presence of
Alzheimer’s disease and/or other dementias based on features common to all types of dementia but distinct from cerumen
from healthy donors.
Specific Aim III: Development of machine learning prediction models to distinguish Alzheimer’s disease samples from
other types of dementia using cerumen chemical profiles, and determination of the subset of compounds that are unique to
each type of dementia.
Specific Aim IV: Structural characterization of biomarkers revealed by the machine learning prediction model(s) developed
in Specific Aims II and III.
The results of this work will reveal whether there is a correlation between the lipid profile of cerumen and the presence of
Alzheimer’s disease and related dementias. Structural information will be acquired on the molecules that are responsible
for the differences in healthy and dementia patients. The information revealed would provide the opportunity for future
development of a potential non-invasive method for the rapid diagnosis of Alzheimer’s disease and related dementias.

Public health relevance
PROJECT NARRATIVE Ménière’s disease is a chronic, debilitating and incurable vestibular disorder that produces a recurring set of symptoms including vertigo, tinnitus, imbalance, nausea and/or vomiting, a feeling of fullness or pressure in the ear, and fluctuating, progressive low-frequency hearing loss. Although this disorder was first reported in the 1800s, little progress in understanding its etiology and pathogenesis has been made: diagnosis is protracted and expensive, and the disease has no cure. This research will result in the development of a rapid and cost-effective diagnostic test, and in the long term, reveal a possible molecular basis for the appearance of the disease.